Deciphering how directional cues are relayed into polarized collective cell migration

Project Summary
Cells within epithelial sheets undergo collective cell migration during a variety of processes including tissue
morphogenesis, organ homeostasis, and cancer metastasis. However, we lack a clear understanding of how
epithelial collectives sense directional cues and translate them into polarized movements, particularly in
vertebrates. Through the proposed project, I will establish the zebrafish pronephros (embryonic kidney) as a
tractable, in vivo model of epithelial collective cell migration.
During development, the epithelial cells of the pronephric duct undergo a collective cell migration towards the
anterior of the embryo, driving morphogenesis of the proximal tubule. This migration is powered by the
extension and retraction of migratory protrusions at the basal cell surface. Lumenal fluid flow has been
identified as the directional cue that dictates migration orientation: pronephric epithelial cells migrate against
flow. Therefore, the pronephric epithelium is an ideal yet underutilized system to study how cells sense and
relay directional information during collective migration, as both the upstream polarizing cue (fluid flow) and the
downstream readout (anterior migration) are known.
Collective migration is often regulated by polarity modules that coordinate cytoskeletal behaviors. I hypothesize
that the zebrafish Fat1a/LarA/LarB proteins function as a migratory polarity module that orients pronephric
protrusions in a flow-dependent manner. In Aim 1, I will test this hypothesis through live-imaging of migration in
wildtype and polarity-mutant embryos. By mechanically altering pronephric flow in embryos expressing tagged
polarity proteins, I will determine if the Fat1a/LarA/LarB polarity module localizes in a flow-dependent manner.
Cilia have long been speculated to function as flow sensors in the pronephric epithelium. I hypothesize that
mechanosensitive sensory cilia detect flow via the Pkd2/calcium signaling pathway. In Aim 2, I will test this
hypothesis by performing live calcium imaging to ascertain if there is a population of cilia exhibiting flow-
responsive calcium signaling. Engineering of a ciliary-trafficking Pkd2-mutant will reveal if ciliary Pkd2 is
required for migration.
Together, the proposed experiments will shed light on how epithelial cells translate directional cues into
polarized migration, advancing our understanding of kidney development. Moreover, through completion of
these aims, I will learn essential skills in zebrafish genetics, molecular cloning, and live-imaging that will be key
to the success of my future independent research lab.

Public health relevance
Project Narrative Collective cell migration drives tissue morphogenesis and organ homeostasis in a vast diversity of animal species, yet we understand little about how epithelial cells sense and interpret the directional cues guiding migration events. The proposed study will establish a tractable, vertebrate model of epithelial collective cell migration, the developing zebrafish pronephros (embryonic kidney), to parse the cellular mechanisms guiding collective migration in a living, developing organ. Long term, understanding the molecular relay guiding collective polarization and migration of epithelial cells will be key in the treatment of developmental diseases and in the engineering of tissues and organs.